Function of Inhibitor of DNA binding (id) genes in the circadian system

DESCRIPTION (provided by applicant): Circadian rhythms are an integral component of life, structuring temporal patterns of biochemistry, physiology and behavior. These cycles are driven by an internal biological clock with an endogenous <24 hr period. The master circadian pacemaker is located in the mammalian hypothalamic suprachiasmatic nucleus (SCN). Disorders of the circadian timing system have been linked to a mental illness and metabolic disorders and understanding the neurobiology and physiology of circadian rhythms should lead to the development of new medical treatments. We propose to study the role of Inhibitor of DNA-binding (Id) genes as potential modulators of the mammalian circadian system. Our preliminary studies reveal that Id genes are rhythmically expressed within the SCN and peripheral tissues; that Id2 null mice show circadian disorder phenotypes, including an enhanced speed of reentrainment of the clock following a large time-zone transition; the ability for ID proteins to inhibit the activity of known clock components; and that a subset of normal circadian outputs in the liver are disrupted in Id2 null mice. Our proposed research will focus on 1) characterizing the protein-protein interaction between ID2 and canonical clock proteins CLOCK, BMAL1 and other relevant bHLH transcription factors; 2) define the molecular basis for the described phenotypes, utilizing both traditional methods of gene and protein expression visualization, and real-time analysis of gene/protein expression using the mPER2-LUCIFERASE mouse system; and 3) examine the role of ID2 in regulating transcriptional pathways of clock output, focusing upon mouse hepatic and metabolic systems. It is expected that these collective studies will provide a greater understanding of the role of Id genes in the molecular clockwork of the mammalian central and peripheral circadian clocks.

Public health relevance
PUBLIC HEALTH RELEVANCE: Disorders of the circadian timing system have been linked to mental illness, such as depression and sleep disorders, and metabolic disorders, and understanding the neurobiology, physiology and molecular basis of circadian rhythms should lead to the development of new treatments. We propose to study the role of Inhibitor of DNA-binding (Id) genes as components of the mammalian circadian system. It is expected that these collective studies will provide greater understanding of the role of ID transcriptional regulators in the molecular clockwork of the mammalian central and peripheral circadian clocks. Disorders of the circadian timing system have been linked to mental illness, such as depression and sleep disorders, and metabolic disorders, and understanding the neurobiology, physiology and molecular basis of circadian rhythms should lead to the development of new treatments. We propose to study the role of Inhibitor of DNA-binding (Id) genes as components of the mammalian circadian system. It is expected that these collective studies will provide greater understanding of the role of ID transcriptional regulators in the molecular clockwork of the mammalian central and peripheral circadian clocks. __SpecificAimsTextDelimiter__ A. Specific Aims: Our long-term goal is to be able to understand the mammalian circadian clock at the gene expression level and in the context of downstream regulation of physiology and behavior relevant to human health. We are interested in the operation of the molecular clock to generate a self-sustained stable 24 hr rhythm in gene and protein expression; how the clock is synchronized by the external environment; and how the molecular clock apparatus regulates downstream output genes and proteins that impact directly the overt physiology and behavior of the organism. The following three Specific Aims are based on our Preliminary Studies and are designed to test the hypothesis that Inhibitor of DNA binding (Id) genes, and in particular Id2, are modulators of the circadian clock. We propose to characterize the role of Id genes in (a) the operation of the core oscillator mechanism, including pacemaker amplitude; (b) the phase-resetting mechanism of the clock, and (c) the regulation of physiological and behavioral rhythmic outputs. Specific Aim 1. Define the interaction of ID2 with canonical clock components. We have identified a potential circadian clock factor, ID2, that appears to modulate circadian responses to photoentrainment, and influence the stability of the circadian clock, as monitored by the level and 24 hr distribution of its locomotor activity output. In Specific Aim 1, we will follow up our discovery that ID proteins can interfere with activity of CLOCK:BMAL1 in the circadian feedback loop. To establish the role of ID proteins at the level of the core oscillator we will examine the ability for ID proteins to bind directly with CLOCK, BMAL1 and NPAS2 proteins using a combination of protein-protein interaction assays: co-immunoprecipitation, mammalian 2-hybrid, co-immuno fluorescence and chromatin-immunoprecipitation approaches. Specific Aim 2. To characterize the circadian molecular phenotype of the Id2 mutant. We have described various circadian behavioral phenotypes for the Id2 null mouse and have begun to examine how the mutation affects the expression of molecular components of the clock and how these changes may underlie these behavioral phenotypes. In Specific Aim 2, we will further explore the role of ID2 to regulate the circadian system by determining the molecular basis for the observed behavioral circadian phenotypes. Our studies in part will be based on the hypothesis that ID2 is interacting with CLOCK and BMAL1 and/or other bHLH components of the clock. We will utilize the real-time gene reporter mPER2::LUCIFERASE mouse system to explore the role of ID2 at the level of individual tissues. We will correlate the behavioral/physiological phenotypes of Id2-/- mice with molecular events in SCN using both living hypothalamic brain slice explants and in Id2-/- mouse embryonic fibroblasts. In order to characterize the effects of the mutation in vivo and to test the hypothesis that ID2 acts as a regulator of pacemaker amplitude, we will study the circadian and photically-induced expression of cock genes within the SCN of Id2 null mice and their wild type counterparts. Specific Aim 3. Investigate the role of ID2 in clock output. We have revealed that ID2 protein is rhythmically expressed in the liver and that a series of genes are misregulated in the absence of ID2, including a cohort of clock controlled genes (ccgs). We have begun to focus upon gene pathways associated with rhythmic control of lipid metabolism. In Specific Aim 3, we will test the hypothesis that ID2 is functioning as a primary output gene regulating circadian clock output at the level of ccgs transcription. We will investigate the required regulatory elements in the Id2 promoter that allow for the mRNA rhythm, investigate the rhythmic nature of ID2 protein levels in the SCN, and determine which ccgs in the liver are misregulated in the absence of Id2. We have identified a metabolic phenotype in the Id2-/- mouse, and we hypothesize that this is produced by abnormal ccg regulation of lipid metabolism pathways. We will characterize the phenotype at the biochemical level. These projects are complementary and mutually enriching, each incorporating genetic, molecular, biochemical and behavioral techniques. The experiments will ultimately lead to an understanding of the function of Inhibitor of DNA binding genes in the circadian system, and will likely provide a molecular pathway by which circadian oscillators within central and peripheral tissues may regulate organ-specific function throughout the 24 hour day.